Collaborative Research Training in Thrombosis and Inflammation

This is the first competitive renewal of a T32 program to prepare postdoctoral trainees for
collaborative research careers in two inter-related topics: thrombosis and inflammation. There is
increasing evidence of a direct relationship between thrombosis and inflammation, or
thromboinflammation, in numerous human diseases. Inflammation contributes to the pathogenesis of
thrombotic disorders such as stroke and coronary artery disease, while thrombosis influences disease
severity in inflammatory conditions such as the novel coronavirus 2019 (COVID-19), sepsis,
autoimmune diseases, and cancer. Despite the close links between thrombosis and inflammation, to
our knowledge, this is the only T32 program in the nation focused specifically on both processes. The
Center for Translational Research on Inflammatory Diseases (CTRID) at Michael E. DeBakey VA
Medical Center and the Division of Thrombosis Research at Baylor College of Medicine sponsor this
collaborative training program with rigorous research opportunities and close mentoring by faculty.
The group of 19 faculty mentors includes 9 NIH-funded investigators and 7 VA Merit-funded
investigators; 11 of the mentors are physician-scientists and the balance are non-physician scientists.
The major strengths of our program include: 1) a cohesive and highly collaborative group of
successful mentors with research expertise in relevant topics for our program, including platelets,
neutrophils, microvascular thrombosis, stroke, cancer, sepsis, autoimmunity, inflammatory conditions
in lung, bone, and infection, among others; 2) a unique combined curriculum with shared didactic and
clinically- oriented training for physician and non-physician trainees; and 3) it is based in a thriving
research center committed to mentoring, including a weekly seminar series that consists of > 60%
speakers with scientific interests aligned with the themes of this T32. In addition to training physician-
scientists in biomedical research, PhD scientists will be trained in translational medicine offering a
direct interaction with patients with clinical conditions related to the focus of this T32. PhD trainees
are paired with physician trainees during these clinical practicums; this collaborative aspect of the
program teaches PhD postdoctoral fellows the importance and benefit of conducting research in
collaboration with physician-scientists and vice-versa. The program consists of 2-3 years of research
training, enriched by didactic courses, an outstanding seminar series and a vibrant scientific
environment. Successful renewal of this T32 on thrombosis and inflammation will continue to pave
the way for new biological insights and novel ways of prevention and treatment of thrombotic-
inflammatory disorders by educating future physician- and non-physician scientists for collaborative
research careers in thrombosis and inflammation.

Public health relevance
This is an institutional training program to train physician and non-physician (PhD) scientists in a collaborative manner to become research leaders in two closely related areas: abnormal formation of blood clots (thrombosis) and the body’s response to injury or infection (inflammation). Thrombosis and inflammation are present in a broad range of severe human diseases in need of greater research, ultimately leading to advances in health.